Identifying the genetic basis of variably protease-sensitive prionopathy

PROJECT SUMMARY
First characterized one decade ago, VPSPr is a rare neurodegenerative disease that presents clinically as
Lewy body dementia or frontotemporal lobar degeneration but has been neuropathologically linked to deposits
of infectious but protease-sensitive prion protein (PrP) aggregates. VPSPr cases lack mutations in the prion
protein gene (PRNP) but 42% of cases have a positive family history, consistent with a genetic disease of
moderate penetrance. We will apply whole exome sequencing and deep targeted sequencing to query the
genetic basis of VPSPr. Identification of a genetic cause of VPSPr will aid in the differential diagnosis of prion
disease and Alzheimer’s-related dementias, validate new genomic technologies for understanding
neurodegeneration, and identify new cellular pathways that lead to neurodegenerative disease.

Public health relevance
PROJECT NARRATIVE This study will apply genomic technologies and algorithms to identify the cause of a unique neurodegenerative disease of unsolved, likely genetic, origin: variably protease-sensitive prionopathy (VPSPr). Identification and functional validation of a genetic cause will shed light on cellular pathways that cause neurodegeneration and will improve the differential diagnosis of dementia.